Core A: Administrative Core

CORE A: SUMMARY/ABSTRACT
The Administrative Core (AC) will coordinate all scientific, administrative, outreach, and educational activities
of the U-M Udall Center. The central objective of the AC is to facilitate realization of the scientific and educational
goals of the U-M Udall Center. The Executive Committee (EC) of the AC will be the ultimate decision-making
body for all Center administrative, scientific, and educational policies. The EC, composed of all Project and Core
Leads, including the Catalyst Project Lead, will be assisted by Internal and External Advisory Committees, which
will review Center activities annually. Beyond its oversight of scientific, administrative, and fiscal matters, the
AC will be responsible for community outreach and trainee education. The AC will work to publicize Center
goals and discoveries. The principal vehicles for communicating this information will be the U-M Udall website
and annual research participant education symposia. The AC will supervise enhancement of the scientific
training of all Center trainees, each of whom will work under the supervision of a Project Leader and have their
progress reviewed annually by the EC. The AC will provide enhanced mentorship for the Catalyst Project Lead
and oversee the training of a Udall Research Fellow.